Elucidation of the interactome for the bioactive disaccharide Man(B1-4)GlcNAc

PROJECT SUMMARY
Some autoimmune diseases, including systemic lupus erythematosus or “lupus,” are now known
to occur because of the pathogenic excess of an intracellular disaccharide called Man(b1-
4)GlcNAc. The accumulation of this disaccharide in cells can lead to the erroneous activation of
immune responses, leading to autoimmunity. The molecular mechanisms through which Man(b1-
4)GlcNAc regulate autoimmunity remain unknown, due to the difficulties of capturing the
intracellular interactors and receptors of free oligosaccharides, like Man(b1-4)GlcNAc. We will
use a chemoproteomic mass spectrometry-based approach to elucidate the interactome of
Man(b1-4)GlcNAc to identify its functional receptors. The accomplishments resulting from this
work will result in an enhanced understanding of aberrant glycosylation and the bioactivity of free
Man(b1-4)GlcNAc, as well as pave the pathway for studying the interactomes of intracellular free
oligosaccharides.

Public health relevance
PROJECT NARRATIVE Free oligosaccharides represent an understudied set of bioactive molecules. We will use chemoproteomic mass spectrometry-based technologies to elucidate the interactome of Man(b1- 4)GlcNAc, a bioactive disaccharide implicated in autoimmunity. This interactome will lead to an enhanced understanding of the molecular mechanisms through which free oligosaccharides exert important biological activity.